Tolerogenic Dendritic Cells via Synergistic Drug Loaded Microparticles for Transplantation Tolerance

Project Summary
Kidney transplants, despite their utility in treating renal failure, carry significant risks, particularly after successful
surgery due to the potential for immunological rejection. Aggressive immunosuppressive regimens have been
designed to limit this risk but are fraught with side effects such as increased risk of cancer and infection. More
precision immunosuppression that selectively generates tolerance towards donor kidney antigens are necessary,
but to date no selective therapies have been developed. Here, we present a proof-of-concept study for a cell-
based therapy to generate donor-specific immune tolerance. We will engineer potent tolerogenic dendritic cells
(tolDCs) that can be infused into donor kidneys prior to transplantation, facilitating presentation of donor antigens
and influencing antigen specific T regulatory responses; thereby selectively suppressing only donor specific
immunity. Our engineered tolDCs, also known as Push/Pull particle tolDCs (PPP-tolDCs) will contain
microparticles loaded with a combination of two synergistic tolerogenic drugs (known as the push/pull particle)
that will provide sustained drug release. These push/pull drug combinations were identified via molecular
screening and generate tolDCs which influence more potent antigen specific Treg responses. We hypothesize
that these two innovations, the push/pull drug combination and encapsulation in sustained release
microparticles, will function cooperatively to generate highly potent, long-lived tolDCs, which in turn generate T
regulatory responses. In this proposal, we will validate that push/pull drugs can be loaded into microparticles
and effectively influence naïve dendritic cells towards tolDCs phenotypes by modulating the inhibitor/agonist
loading ratio. We will further explore PPP-tolDCs interaction with donor-specific kidney antigens from various
sources and ability to influence donor-specific T regulatory responses. This is the first step in developing PPP-
tolDCs towards a cell therapy that can generate donor kidney tolerance by being infused into donor kidneys prior
to transplantation.

Public health relevance
Project Narrative Long-term usage of immunosuppressants after transplantation is a serious health risk. This project seeks to develop a cell-based therapy to induce donor-specific tolerance in kidney transplantation using engineered tolerogenic dendritic cells laden with microparticles releasing synergistic drug combinations. This could potentially replace non-specific immunosuppressive regimens with a single-dose cell therapy.